Core A: Administrative Core

Core A: Administrative Core
Abstract
The administrative core is designed to coordinate and support all the activities of this Program. It
will work pro-actively to assure complete integrations across the Research Projects and Cores
around the theme of “integrative genomics” that is the focus of the program. The Core will be
responsible for overseeing the day-to-day activities of this program and assuring that the overall
goals of the program are achieved. Among other activities, this Core will organize biweekly
meetings of the entire research team, coordinate scientific seminars and workshops, and hold an
annual retreat. We have assembled an External Advisory Committee (EAC) comprising experts
from outside USC in statistical genetics, cancer genetic epidemiology, integrative genomics,
bioinformatics, and high-performance computing. We have also assembled an Internal Advisory
Committee (IAC) drawing on the deep expertise of our colleagues across these same disciplines
within USC. The Core will coordinate an annual meeting of the EAC and quarterly meetings of
the IAC, and it will facilitate additional interactions with EAC or IAC members throughout the year
as needed. The Core will coordinate travel, purchase supplies, monitor budgets, handle
personnel issues, submit annual progress reports, and facilitate recruitment of new investigators,
post docs, and students.
As co-directors of this core, Drs. Gauderman and Siegmund will jointly assume responsibility for
all organizational and financial activities of the project. In addition, Dr. Gauderman will assume
specific leadership of Project activities and Dr. Siegmund specific leadership of Core activities.
These Project- and Core-specific roles will guarantee that both important elements of the overall
program are being adequately administered. They will also establish the infrastructure needed
for effective communications and collaboration across the Projects and Cores. They will co-chair
our IAC and plan one annual meeting of the EAC as well as a separate annual scientific retreat
with all program and core investigators. Leveraging their experience as Director of the Division
of Biostatistics (Dr. Gauderman) and Director of our Biostatistics and Epidemiology Education
Program (Dr. Siegmund), they will assure that the ambitious goals of this program are fully
coordinated and supported.

Public health relevance
Narrative The Administrative Core will provide scientific oversight, enhance communications among investigators, and support all of the day-to-day administrative needs of this program. It will work proactively to assure complete synergy across the Research Projects and Cores around the theme of “statistical methods for integrative genomics” that is the focus of the Program.